Automated ascertainment of bleeding and target lesion revascularization after percutaneous coronary intervention (PCI) using electronic health record (EHR) data

PROJECT SUMMARY
Percutaneous coronary intervention (PCI) is the most common cardiac procedure with over 650,000 PCI
performed annually in the U.S. Post-PCI complications which occur in a significant proportion of patients are
associated with an increased risk of morbidity and mortality. Reliable ascertainment of post-PCI events is
important for performance measurement, submission to disease registries, clinical trials, and for cardiac
catheterization laboratory (CCL) safety monitoring. Claims based detection of PCI complications is inadequate.
Assessing post-PCI events reliably requires an in-depth manual chart review, which incurs a significant
provider and administrative burden. However, with advances in health information technology and nationwide
adoption of electronic health record (EHR) systems, it possible to utilize EHR for the automatic derivation of
clinical events. Dr. Murugiah proposes to create and validate automated algorithms which can be applied to
EHR data to detect two important post-PCI events which are a common focus of clinical trials and quality
improvement efforts – in-hospital bleeding and 1-year target lesion revascularization (TLR). Using EHR data at
a large health system, Dr. Murugiah will develop a hybrid algorithm to detect major bleeding post-PCI by
leveraging structured data fields such as laboratory values, as well as unstructured data such as imaging
reports, cardiac catheterization reports, and progress notes incorporating Natural Language Processing (NLP)
techniques (Aim 1). Similarly, using cardiac catheterization reports for patients undergoing repeat
revascularization within 1 year, an algorithm will be developed to detect TLR (Aim 2). Both algorithms will be
externally validated using EHR data from another large institution. The final algorithm will be implemented into
a tool generating scheduled reports of bleeding and TLR, to be fed back to the quality assurance team for the
CCL and to individual operators. Individual operators will be surveyed to obtain feedback about the algorithm,
reporting process, and their perceived benefit. The final tools will be made open source (Aim 3). An automated
algorithm for the detection of post-PCI events within EHR can reduce administrative burden, enable the
generation of new knowledge from EHR based observational studies, and enable pragmatic clinical trials.
Further, this project can serve as a proof of concept of the utility of hybrid tools leveraging both structured data
and clinical text for surveillance and quality measurement. Dr. Murugiah has a career interest in studying and
improving the treatment for ischemic heart disease using multidimensional datasets and EHR data to develop
real time risk prediction models and decision support tools, and conduct EHR based comparative effectiveness
studies and clinical trials. During the award period he will leverage the experience of his mentorship team
which includes national experts in cardiovascular outcomes research, clinical informatics, and computational
linguistics. He will also acquire formal training in clinical informatics by completing a Master of Health Science
degree which will provide him the necessary platform to make the transition into an independent investigator.

Public health relevance
PROJECT NARRATIVE Current methods of ascertaining complications after percutaneous coronary interventions (PCI) or ‘stent procedures’ are resource intensive and inadequate. This proposal aims to create and validate hybrid algorithms which use structured and unstructured data from the electronic health record leveraging natural language processing techniques, to reliably detect two important post-PCI events – in-hospital bleeding and 1- year target lesion revascularization. These algorithms will be incorporated into an automated routine which generates scheduled reports on these complications.